Addressing Structural Disorder and Conformational Heterogeneity in Modern Therapeutic Modalities: A Unified X-ray/Cryo-EM QM/MM Ensemble Refinement Toolkit with Enhanced Density-Driven MD

Abstract
Accurate determination of protein–ligand interactions fundamentally shapes drug discovery, directly influencing
lead optimization and therapeutic development. Despite advances in X-ray crystallography and cryogenic
electron microscopy (Cryo-EM), traditional refinement methods still struggle significantly with intrinsic disorder,
flexibility, and conformational heterogeneity. Approximately 69% of Protein Data Bank (PDB) structures contain
missing or unresolved residues, especially at resolutions worse than 2.75 Å. This pervasive issue severely limits
structural accuracy, particularly for complex, therapeutically critical modalities like macrocycles, PROTACs,
cyclic peptides, covalent inhibitors, and metal-containing ligands. Moreover, the accuracy of AI-driven structure
prediction models (e.g., AlphaFold, OpenFold) strongly depends upon high-quality experimental data,
highlighting the urgent need for improved, ensemble-based structural refinement. Conventional refinement
protocols predominantly rely on single-conformer assumptions and simplified stereochemical restraints,
frequently missing critical alternative binding modes and ligand-induced structural changes. Simulated annealing
(SA) methods help avoid local minima but typically converge on single optimized structures, inadequately
capturing true biological flexibility. Conversely, ensemble refinement (ER) explicitly models structural
heterogeneity through simultaneous multi-conformer refinement, capturing relevant functional states. However,
existing ER implementations generally employ simplistic force fields and basic molecular dynamics (MD), limiting
their accuracy, efficiency, and pharmaceutical utility. To overcome these limitations, we propose a novel, unified
X-ray/Cryo-EM pipeline integrating our robust, linear-scaling quantum mechanics/molecular mechanics
(QM/MM) engine (DivCon), advanced density-driven conformational sampling (including omitted loop and
sidechain completion and protonation state determination), automated protomer/tautomer enumeration, and
real-space Z-score density difference (ZDD) scoring (XModeScore). Crucially, this new platform will incorporate
an integrated GPU-accelerated molecular dynamics engine supporting enhanced MD sampling (e.g., replica
exchange, metadynamics, accelerated MD), occupancy/B-factor refinement, and rigorous clustering to efficiently
capture biologically relevant conformational dynamics.
Commercially, our approach directly addresses longstanding pharmaceutical pain points related to structural
ambiguity and disorder, providing chemically realistic, actionable structural ensembles suitable for improved drug
design. By automating ligand and protein preparation, rigorously modeling challenging drug modalities, and
capturing genuine conformational flexibility, our pipeline surpasses current platforms in structural fidelity,
predictive accuracy, and practical applicability to modern therapeutic discovery.

Public health relevance
Project Narrative: The successful completion of this SBIR project will significantly improve the accuracy and reliability of protein and ligand structures determined by X-ray crystallography and Cryo-EM through advanced ensemble refinement techniques. By addressing conformational flexibility, intrinsic disorder, and ligand binding mode variability, our method will generate robust structural ensembles critically needed for modern structure-based drug discovery. Ultimately, these improved structural insights will directly enhance our ability to rationally design effective therapeutics for human disease.